Supplement: Stage II Efficacy Trial of a Culturally Informed Brief Intervention to Reduce Alcohol Related Health Disparities and Treatment Inequities among Latinxs

Project Summary/Abstract (Diversity Supplement)
Rebeca Fierro Perez-Martinez, a PhD student under the mentorship of Dr. Craig Field, is a Hispanic
female from a lower socioeconomic background and first-generation college student interested in an
independent research career investigating health disparities among the Hispanic population. Under the
Diversity Supplement, Rebeca plans to 1) conduct a large-scale systematic review that compares theories and
research on cultural adaptations targeting alcohol related health disparities. This large-scale systematic review
combines two literature reviews: one pertaining to theories of cultural adaptations and the second on current
research evaluating cultural adaptations. Comparing and contrasting these two reviews will allow for
identification of gaps in current research and advancement in the science of cultural adaptations to reduce
health disparities and treatment inequities. In addition, Rebeca will 2) validate a measure of behavior change
based on SDT from the parent study. This measure has not been validated in the context of alcohol use. More
importantly, the group invariance of this measure has not been established in English and Spanish speaking
Hispanics. Under the mentorship of Dr. Field, Rebeca will participate in journal club, research team meetings,
and individual meetings (guided by an individual development plan) that will ensure progress of both academic
and research related goals. Rebeca will also benefit from collaboration with the co-investigator, Dr. Castro, on
the parent study who is a female of Hispanic descent. She will also pursue outside training opportunities which
will be supplemented with directed reading related to conducting systematic reviews and confirmatory factor
analysis. To further enhance her professional development, she will present at and attend professional
conferences related to research on alcohol. Mrs. Perez-Martinez intends to pursue a post-doctoral fellowship
(i.e., F32 or T32) or tenure track faculty position allowing her to pursue an independent research career (K01
or R01/03/21 or 34) to assess the effectiveness of positive psychology-based interventions to reduce alcohol
use and related problems including mental health outcomes.

Public health relevance
Project Narrative This Research Supplement to Promote Diversity for the currently funded Stage II Efficacy Trial of a Culturally Informed Brief Intervention to Reduce Alcohol Related Health Disparities requests two years and four months of funding to support the research and training of Rebeca Fierro Perez-Martinez, a PhD student. Dr. Field (PI of the R01) will directly mentor Rebeca (PI of the Diversity Supplement) who is a Hispanic female from a lower socioeconomic background and is a first-generation college student. Rebeca Fierro Perez- Martinez is committed to a research career in Hispanic health disparities and intends to pursue a post-doctoral fellowship or tenure track faculty position at an R1 institution where she can pursue an independent research career.